Dissecting the Heterogeneous Molecular Mechanisms Underlying Multiple Sclerosis Progression

Abstract
Multiple sclerosis is the most common cause of non-traumatic disability in young adults, with an estimated total
economic burden of $85.4 billion. Irreversible disability accumulation is the most challenging, unmet need
in care for people with multiple sclerosis (pwMS) and drives socioeconomic burden. Disability
accumulates in two different clinical contexts: Progression independent of relapse activity (PIRA, ~ 80%) and
relapse-associated worsening (RAW, ~20%). Both are driven by a complex interplay of immune- and non-
immune processes. Body fluid biomarkers offer a unique opportunity to disentangle the complicated
pathophysiology of progression, which cannot be studied with sufficient fidelity in vitro or using animal models. I
spearheaded a collaboration between US and European cohorts with > 12,000 visits to assess neuroaxonal
injury in pwMS. This work revealed that central nervous system (CNS) injury occurred months to years preceding
progression (pre-PIRA/ pre-RAW). Building upon this research, the primary objective of this grant is to elucidate
the cellular constituents and related mechanisms of CNS injury during pre-progression.
To that end, I plan to acquire the skills and tools to perform a proteome-wide analysis of serum samples from
two international cohorts from the US and Germany. The Olink® Explore HT kit can measure up to 5400 proteins
using antibody-based proximity extension technology. Among those proteins are many CNS-driven markers that
cannot be measured otherwise. This proteomic analysis will help us determine the magnitude of astrocyte
response during pre-PIRA, define the severity and dynamics of oligodendrocyte and myelin injury in pre-PIRA
and how it relates to neuroaxonal injury and characterize the role of synaptic injury during that critical window of
CNS injury (Aim 1). The dataset generated during Aim 1 will be further analyzed in Aims 2 and 3 to define the
driving mechanisms of PIRA at different disease stages, how PIRA differs from RAW, and what distinct markers
can characterize each process.
This project is anticipated to unravel a set of proteins/ protein pathways of particular significance for MS
progression. In my future independently funded lab, I aim to build on this work by establishing the next-stage
progression-focused assays and defining their clinical context of use in MS.

Public health relevance
Project Narrative The driving mechanisms behind the irreversible progression in multiple sclerosis remain largely unknown. Leveraging advanced proteomics-based blood biomarker tools, this project aims to define the protein pathways involved during the crucial period before the onset of disease progression. The insights gained from this study can help to tailor targeted and personalized therapeutic strategies.